Artificial Intelligence Applied to Video and Speech for Objectively Evaluating Social Interaction and Depression in Mild Cognitive Impairment

Project Summary/Abstract
The decreases in social engagement and the feeling of depression and loneliness are reported to be highly
correlated with the progression of mild cognitive impairment (MCI). However, previous studies primarily relied
on retrospective survey analysis, which lacks continuously quantifying such behavioral biomarkers in the real
world. Recent advances in artificial intelligence (AI) made it capable of assessing human physical and mental
activities in the real world. Yet, those techniques are mainly evaluated on normal populations, whose behaviors
are distinctively different from MCI individuals. This proposal aims to validate AI technologies applied to video
and speech for objectively evaluating social interaction and mental health in a MCI population. Successful
completion of this proposal will provide an important step toward our long-term goal, which is a large-scale
longitudinal study for continuous, objective quantification of MCI progression in the real world. Our general
hypothesis is that the subtle yet important changes in social engagement and mental health during real-world
interactions of MCI individuals can be continuously captured and quantified for cognitive impairment. For our
study, MCI patients will be recruited with balanced race and ethnic backgrounds from the urban Atlanta, GA,
area. In Aim 1, social engagement analysis will be conducted at Cognitive Empowerment Program (CEP) at Emory
Goizueta Alzheimer’s Disease Research Center. The CEP space is installed with an edge computing-based, privacy-
preserving, low-cost patient monitoring system having multi-modal sensors including cameras. At CEP, the
recruited MCI patients will be participating in physical and cognitive training programs provided by therapeutic
service professionals. MCI patients' social engagement features detected from the multi-camera network system
will be used to predict the Perceived Social Support Scale (PSS) and Montreal Cognitive Assessment (MoCA)
scores of corresponding patients. In Aims 2 and 3, depression and loneliness analysis is conducted with video
recordings of the Cognitive Assessment Interview (CAI) from the recruited MCI patients. For gold standard
depression and loneliness scales, MCI participants will provide Geriatric Depression (GDS) and UCLA Loneliness
scales, respectively. From the video recordings, the facial (Aim 2) and speech (Aim 3) behavior of MCI patients
will be analyzed for the prediction of GDS, UCLA Loneliness, and MoCA scales. The validation of techniques in
this proposal is expected to have a significant impact on quantifying MCI progressions as these techniques can be
readily extended to quantifying other MCI-related behaviors in the real world, such as wandering or apathy. Also,
this proposal’s findings in social and mental health features can drive novel hypothesis generation to power
clinical trials for developing novel treatments for cognitive decline. This research aligns with the NIA’s mission to
understand the diseases and conditions associated with the aging process in order to extend healthy years of life
by supporting behavioral research on aging and disseminating research information to the scientific community.

Public health relevance
Project Narrative/Public Health Relevance Detecting early signs of mild cognitive impairment (MCI), which normally precedes Alzheimer’s Disease (AD), is important for preventing further cognitive decline as individuals with MCI can still function independently. With the progression of cognitive impairment, MCI individuals experience subtle yet important decreases in social engagement with more feelings of depression and loneliness. The goal of this proposal is to validate an artificial intelligence system that can automatically monitor and quantify real-world social interaction and mental health behaviors for a MCI population, which is an important step toward evidence-based therapies for managing cognitive impairment.